Cellular interactions between TGF-beta pathway members and epignetic regulators in liver and gastrointestinal cancers

Contact PD/PI: Mishra, Lopa Project-001 (001)
ABSTRACT
Transforming Growth Factor-Beta (TGF-β) is a potent regulator of stem cell differentiation, epigenetic
alterations, inflammation, tumor suppression, and tumor progression. However, to date, the role of TGF-β
members at these specific stages in liver and gastrointestinal (GI) tumors remains poorly delineated. We have
uncovered a unique role for TGF-β signaling molecules, Smad3 and its adaptor β2SP, in suppressing stem cell
transformation into cancer. We observe a nearly identical phenotype to a human stem cell disorder with a high
risk of cancer (that include liver and GI cancers), Beckwith-Wiedemann syndrome (BWS), in TGF-β signaling-
deficient (β2SP+/-- and β2SP+/-/Smad3+/-) mice that we have generated. We observe a de-regulation of multiple
molecules including stem cell genes such as ALDH1 and increased levels of molecules such as telomerase
(TERT) in our TGF-β signaling-deficient mouse mutant tissues and BWS-cell lines, with disruption of
chromatin insulator CTCF-driven regulation of TERT. Our preliminary data from HCC TCGA analyses reveal
a significant expression pattern correlation between the Sirtuin pathway and TGF-β members. In addition,
SIRT6 levels are decreased in HCCs, and in tissues from our mouse mutants deficient in TGF-β signaling;
SIRT6 mutants develop a severe liver inflammation and cancer (in older mice), providing both a precancerous
and an aging cancer model for HCC. Our hypothesis is that the tumorigenesis occurs through a lifting of
chromatin modulation and epigenetic alterations by defective TGF-β/CTCF-dependent regulation of TERT,
and through interactions with SIRT6 that normally suppress tumor promoter genes, thus leading to
subsequent disruption of stem cell homeostasis that drives liver and GI cancers.
To explore this hypothesis, we propose the following aims: Aim 1: Define mechanisms by which the
tripartite complex of CTCF, β2SP and Smad3 regulates TERT and SIRT6, as well as stem cell homeostasis;
Investigate the collaboration between TGF-β, TERT and SIRT6 through in vitro and in vivo interactions,
potentially providing new understanding into switches involved in stem cell driven tumorigenesis. Aim 2:
Develop a comprehensive molecular portrait of the TGF-β pathway, including the Sirtuin family and TERT in
liver and GI cancers, extending the current analysis of HCCs through TCGA, cBioPortal and Oncomine
databases. The insight into the effector role of the TGF-β signaling pathway and our mouse models, provide a
powerful approach for investigating the switch to stem cell transformation in HCC and GI cancers.
Project Summary/Abstract Page 334
Contact PD/PI: Mishra, Lopa Project-001 (001)

Public health relevance
PROJECT NARRATIVE TGF-β plays a crucial yet complex role in cancer- that includes the following: stem cell homeostasis, profibrotic, immune modulatory, tumor suppressor and tumor progression. We have discovered a key effector role for the TGF-β pathway in suppressing cancers in a human stem cell disorder. By using human TCGA analyses and genetically-engineered mouse models, we propose to dissect the multifaceted and context- dependent driving roles of TGF-β, together with major pathways in chromatin and epigenetic regulation, in liver and gastrointestinal malignancies. Project Narrative Page 335